Simultaneous Targeting of Immunoglobulin G and M Using Endopeptidase for Humoral Rejection in Xenotransplantation

Abstract
The xenotransplantation field has achieved commendable success through the utilization of the non-human
primate (NHP) model. Studies to date serve as a proof-of-concept, demonstrating that pig-to-NHP or human
transplantation can be achieved without hyperacute rejection and providing insights regarding the human
immune response to a xenograft. Xenotransplantation survival in nonhuman primate recipients has markedly
improved in the past decade due to 1) the use of genetically modified pig donors, and 2) the treatment of
recipients with costimulation blockade, in particular targeting CD40-CD154 signaling pathway. Recently, a pig-
to-NHP xenokidney transplantation model employing a TKO pig with additional human proteins under anti-
CD154mAb immunosuppression showed the longest graft survival close to 2 years. However, it is imperative to
not overlook the outcomes of animals that did not attain long-term graft survival. In this study, 40% of NHP
recipients (6 out of 15 animals) did not survive beyond 2 months. The consistent occurrence of early xenograft
failures in virtually all NHP xenotransplantation studies is a matter of concern. Considering the two cases of
clinical cardiac xenotransplantation outcomes (patient survival of 61 and 40 days) are coincide with the early
failure shown in NHP model, clear mechanistic explanation and intervention for this phenomenon is urgently
required prior to clinical xenokidney transplantation. Interestingly, we and others observed a clear antibody-
mediated rejection (AMR) in early xenograft rejection with high levels of preformed and de novo xenoreactive
IgG/IgM. Removal of preformed IgG antibodies with cleaving enzyme such as IdeS (Imlifidase) has shown
therapeutic promise in organ transplantation for sensitized recipients. However, strategies to selectively
remove IgM, which precedes IgG in triggering immune dysfunction are lacking. Especially, preformed and de
novo polyreactive IgM antibodies against porcine glycans were considered detrimental in pig-to-human and
pig-to-NHP xenotransplantation. Therefore, in the present study, our focus is on targeting both xenoreactive
IgG and IgM using novel endopeptidase(s), IceMG, to eliminate early antibody-mediated injuries. We
hypothesize that mitigating the early injuries caused by preformed and/or de novo xenoreactive IgG/IgM
prolongs xenograft survival by preventing AMR. This study will validate the role of xenoreactive IgG and IgM in
early xenograft rejection, identify potential xenograft injuries independent of AMR, and assess the efficacy of
the novel endopeptidase as a therapeutic option for xenotransplantation.

Public health relevance
PROJECT NARRATIVE Animal to human transplantation (xenotransplantation) has long been proposed as a therapeutic strategy to address the ongoing organ shortage in transplantation, most impactfully for highly sensitized patients who are more likely to reject transplanted organs. While xenotransplantation outcomes in animal models have improved over the last years, a high fraction of those recipients still exhibited early xenograft rejection with antibody- mediated rejection (AMR) feature, which remains a common barrier preventing long-term graft survival and clinical translation. Therefore, this project seeks to evaluate a novel recombinant endopeptidase, IceMG, which cleaves both IgM and IgG simultaneously in a preclinical nonhuman primate model, aiming to offer insights and potential treatment options for addressing AMR in xenotransplantation, with anticipated future advances moving into clinical trials to further prolong xenokidney transplant function and patient survival, thereby extending the lifespan and quality of life of patients with kidney failure.